A mechanism of lipid accumulation in brown adipose tissue

PROJECT SUMMARY
Human variants in the cytoskeleton-associated protein ankyrin-B (AnkB) have been identified as risk factors for
metabolic disorders, including type 2 diabetes and obesity. Mice harboring these variants exhibit AnkB deficiency
in metabolic tissues including white (WAT) and brown adipose tissue (BAT), and develop age and diet-dependent
adiposity, insulin resistance, and glucose mishandling. Simultaneous AnkB deficiency in WAT and BAT also lead
to lipid accumulation in BAT (BAT “whitening”) and to decreases in energy expenditure and oxygen consumption.
These findings suggest that AnkB may function as an important regulator of lipid metabolism and systemic
metabolic regulation through its unexplored roles in BAT. The overarching goal of this study is to elucidate the
cell-autonomous roles of AnkB in BAT. We hypothesize that AnkB regulates lipogenesis in BAT and is required
for maintaining the energetic and glucose-handling capacity of BAT in response to metabolic stressors. To
answer these questions, we proposed to determine the molecular mechanism of association with AnkB
modulation of glucose handling and lipid metabolism in brown adipocytes (aim 1). Additionally, we will define
how AnkB deficiency in BAT regulates energy balance and systemic metabolic homeostasis in response to the
metabolic stressors, such as aging and high-fat diet (aim 2). Completion of the proposed studies will provide
functional insights into AnkB’s contribution to BAT physiology and metabolic homeostasis. The proposed work
will also shed light into the pathophysiological mechanism through which human AnkB variants contribute to
metabolic diseases.

Public health relevance
PROJECT NARRATIVE Brown adipose tissue (BAT) is an essential regulator of energy balance and glucose homeostasis. Human genetic variants in ankyrin-B, a scaffolding protein expressed in several metabolic tissues, including brown adipose tissue, lead to increased risk of metabolic diseases such as obesity and type 2 diabetes (T2D). This project will investigate the role of ankyrin-B in glucose uptake and fatty acid synthesis in BAT, as a likely mechanism underlying dysregulation of lipid metabolism, energy balance, and systemic metabolic homeostasis caused by ankyrin-B deficiency in BAT and will further our knowledge of BAT physiology and the contribution of deficits in BAT function to the development of obesity and T2D.